Genetic Core

Core B: Genetics Core The Genetics Core continues to build on the highly-successful service functions provided to PPG researchers in the previous grant. With highly-trained personnel and specialized instrumentation, this Core provides our researchers with transgenic mouse production, knock-out mouse production, high quality DMA sequencing and microsatellite genotyping. These facilities were well-known among national Core labs for their outstanding technical competence and cost-effectiveness. The transgenic animal lab, under the management of Dr. Thomas Saunders, has accumulated 18 years of experience producing transgenic mice, and 15 years experience in genetic knock-out methodology. The DMA sequencing lab has been in operation for 14 years, the last 12 of which were under the direction of Dr. Lyons. That laboratory has an outstanding reputation for reliability and cost-effectiveness. They recently acquired an Illumina BeadStation 500GX, and have begun providing high-throughput SNP typing services. All four of the PPG projects depend heavily on the Genetics Core. The services described here will be provided on a recharge basis, with members of this Program Project receiving preferential discounts.